Impact of Titanium-mediated Oxidative Stress on LPS/TLR4 Signaling

PROJECT SUMMARY
Peri-implantitis, an inflammatory disease resulting in destruction of peri-implant soft tissue and bone, remains a
major obstacle to dental implant survival due to a lack of effective treatment strategies for this disease. Until
recently, oral bacteria were considered a primary factor triggering peri-implantitis as observed for periodontal
diseases. However, peri-implant disease research has shifted focus to understanding oral immune mechanisms
which sense external cues in the oral cavity and maintain homeostasis with the oral microbiome. One well-
established mechanism of oral immune surveillance is Toll-like receptor (TLR) sensing of lipopolysaccharide
(LPS), an endotoxin and component of gram-negative bacteria, ubiquitous in the oral cavity. The regulation of
the LPS/TLR4 axis, known as endotoxin tolerance, is an important mechanism in maintaining oral homeostasis.
TLR4 activation triggers signaling cascades involved with multiple cellular functions including immune cell
recruitment, reaction oxygen species (ROS) generation to neutralize invading microbes, and proinflammatory
cytokine secretion. The LPS/TLR4 axis is tightly controlled by multiple negative regulators at several stages of
TLR4 signaling cascades which mitigate uncontrolled inflammation resulting in host tissue destruction. During
peri-implant inflammatory disease progression, excess ROS levels, i.e., oxidative stress, occurs, which disrupts
cellular processes including regulation of LPS/TLR4 signaling. Suppression of TLR4 negative regulators is
hypothesized to drive TLR4 overexpression in peri-implantitis, thereby increasing sensitivity to LPS. Titanium
(Ti) particle dissolution from a dental implant surface can accumulate in adjacent peri-implant tissue, and
increasing concentrations of Ti particles are associated with peri-implantitis. However, the role of Ti particles in
mediating peri-implant disease remains to be elucidated. In this proposed study, the impact of implant-derived
Ti particles (iTiPs) on excess ROS production and subsequent dysregulation of the LPS/TLR4 axis is explored.
In Aim 1, transcriptome analysis of human peri-implantitis-affected tissue containing Ti particles is performed via
RNA sequencing, while focused gene translation study for TLR4 signaling, ROS production, their regulators, and
proinflammation cytokines is assessed via immunohistochemistry. In Aim 2, ex vivo Ti particles in human peri-
implant tissue are characterized to generate morphologically similar iTiPs, which are then assessed for induction
of ROS production in monocyte-derived immune cells in vitro. In Aim 3, the ability of iTiPs-induced ROS to
dysregulate LPS/TLR4 signaling, ROS generation, and proinflammatory status is evaluated via gene expression
studies and imaging flow cytometry in vitro and a murine oral mucosal model in vivo. This fellowship will help the
applicant pursue a career as an independent investigator in the field of biomaterials, immunology, and oral
microbiome studies with a focus on LPS/TLR4 signaling to identify potential therapeutic targets for peri-implant
inflammatory disease treatment. Successful completion of this project will fill a crucial knowledge gap by
elucidating the role of iTiPs and its interaction with oxidative stress and TLR4 signaling in driving peri-implantitis.

Public health relevance
PROJECT NARRATIVE Dysregulation of oral mucosal homeostasis is a causative factor underlying peri-implant inflammatory disease. Titanium particles are associated with peri-implantitis, yet the interactions between titanium particles, oxidative stress, and mechanisms maintaining homeostasis such as regulation of lipopolysaccharide/Toll-like receptor signaling have yet to be investigated in the context of peri-implant disease. Understanding the role of implant- derived titanium particles in modulating oral homeostatic mechanisms will lead to identification of future therapeutic targets for peri-implantitis treatment.